CANCER EDUCATION PROGRAM

This project supports a cancer education program at the Dartmouth-Hitchcock Medical Center, Hanover, New Hampshire. New initiatives in a cancer related curriculum for undergraduate medical students, residents, nurses, as well as continuing education programs for physicians, nurses and other health professionals are supported by this program. Portions of the curriculum which emphasize the teaching of cancer prevention, epidemiology, nutrition, cancer control, and surgical and radiation oncology are supported by this application. During this period of support we will establish a new program in oncology nursing education as well as a residency program in radiation therapy. The existing programs of interdisciplinary teaching in tumor cell biology and cancer pathophysiology, staging, and treatment will be revised and improved. Tumor boards and tumor conferences at outlying hospitals, as well as formal seminars, symposia, and other continuing medical education courses, will continue.